Academic-Industrial Partnership for Barrett's Esophagus Detection and Risk Assessment

Summary. This is a Type 2 R01 renewal application to continue studying Barrett’s esophagus (BE), a premalignant condition
wherein the normal squamous esophageal lining is replaced by a specialized metaplastic columnar epithelium in response
to chronic gastroesophageal reflux (GERD). BE patients carry an increased risk of developing esophageal adenocarcinoma
(EAC), a rapidly growing, lethal malignancy (5-year survival <20%) whose incidence in the U.S.A. has increased
exponentially over the past four decades.
The first 5 years of funding by this Academic-Industrial Partnership award have resulted in the creation of a highly
successful new company, Capsulomics (also known as Previse), with the development of a fully licensed commercial
prognostic product to assess future neoplastic progression risk in BE. The current Type 2 renewal proposal will continue
this productive partnership, building on its success while tackling two major clinical dilemmas:
1) The currently accepted marker for EAC risk in BE patients is histologic dysplasia, either high-grade (HGD) or low-
grade (LGD). In many centers, confirmed HGD is treated in the same manner as early-stage EAC, i.e., by endoscopic
eradication therapy (EET). However, unlike HGD, the predictive value of LGD for cancer risk assessment is weak; moreover,
high inter-observer variation in histologic assessment is problematic. Finally, most BE patients never develop LGD or HGD
and thus have no means of gauging their progression risk. Thus, accurate, objective, quantitative biomarkers of
progression risk in BE will be extremely useful.
2) Early-stage esophageal neoplasia is highly curable; however, most EACs are detected at advanced, incurable stages.
Furthermore, only 5% of patients presenting with EAC were previously diagnosed with BE, suggesting that failed BE
detection leads to delayed EAC diagnosis. Thus, better early detection of BE and EAC is needed to improve patient
outcome. However, the current means of detection, upper GI endoscopy (EGD), is too expensive, invasive, and inaccessible
to be practical for population-based screening. Thus, nonendoscopic early BE and EAC detection strategies are needed.
We will tackle these challenges by pursuing the following Specific Aims: 1. Analytically and clinically validate and
commercialize the EsoPredict methylation assay for personalized BE risk assessment; 1A: Perform an expanded analytical
and multicenter clinical validation study of the prognostic assay EsoPredict on FFPE tissue-derived DNAs from 400 patients,
incorporating multivariate analyses; 1B: Develop and implement pathways to introduce and establish EsoPredict into
clinical practice; 2. Develop, validate, and begin commercialization of the EsoDetect diagnostic assay for nonendoscopic
BE diagnosis, using a swallowable-retrievable sponge sampling device; 2A. Build and test a multivariate algorithm on
sponge-derived DNAs from 600 patients with various stages of BE neoplasia, incorporating multivariate analyses; 2B.
Initiate commercialization of the sponge sample-based EsoDetect assay; and 3. Conduct a prospective study of EsoPredict
in tissues and non-endoscopic sponge samples from 350 BE patients, including 260 carried forward from Aim 2.

Public health relevance
We will devise nonendoscopic early BE and EAC detection strategies and develop biomarkers to predict neoplastic progression in BE by 1. Analytically and clinically validating and commercializing the EsoPredict assay for personalized BE risk assessment; 2. Developing, validating, and commercializing the EsoDetect assay for noninvasive BE diagnosis; and 3. Conducting a prospective study of EsoPredict in tissues and sponge samples from BE patients.